LOW SALT, HIGH SALT, &HIGH SALT W/ KHCO3 IN POSTMENOPAUSAL WOMEN

In this study postmenopausal women will have baseline markers of bone metabolism including serum calcium, phosphate, alk phos, sodium, potassium, creatinine, chloride, osteocalcin, PTH, and calcitriol, and 24-hour urine sodium, calcium, deoxypyridinoline, creatinine, potassium, and cyclic AMP. The women will then be adapted to a low salt diet for four weeks and these outcomes repeated. Then they will be randomized to a high salt diet with placebo or a high salt diet with potassium bicarbonate for four weeks and the outcomes repeated.